STUDIES OF THE NEUROLOGIC EXAMINATION OF YOUNG INFANTS

To evaluate approximately 500 infants between the ages of 41 weeks (from conception) and age 4 months corrected gestational age with the Neoneuro a method developed by Dr. Patricia Ellison. This will provide normative scores for this age group.